Leadership, Planning and Evaluation

Leadership, Planning and Evaluation
ABSTRACT
The COHCCC Director has a wide array of advisory input to assist in planning for the Center's future and
evaluating the outcomes of Center programs and policy implementation. The most important of these is the day-
to-day decision-making body, the Cancer Center Executive Committee. This group consists of the traditional
senior leaders of the Center, the Deputy Directors and Associate Directors, as well as several other key senior
members of the Center. All plans either originate in or pass through this group.
Our External Advisory Board continues to play a significant role in reviewing our plans and advising on our course
of action. Our senior leaders, Program Leaders and Core Directors convene in the Cancer Center Leadership
Council. The Shared Resource Oversight Committee reviews all Shared Resources activities and services to
assure compliance and efficiency. Our Clinical Trials Minority Recruitment Committee is charged with increasing
minority enrollment in clinical trials. Our ongoing full Cancer Center retreats and our individual Program retreats
are key for promoting and facilitating key collaborations.
Strategic planning is a dynamic process that is informally woven into the structure of each of our senior
committees, both internal and external. In addition, COHCCC engages in a formal strategic planning process.
Key leadership, including the Cancer Center Director and COH Chief Strategy Officer, meet to outline an
appropriate process for the development of the objectives and an approach for the CCC strategy document. The
approach includes data collection and analysis, multiple interviews with key CCC stakeholders, and an iterative
review and approval process of the final deliverable. By design, the plan outlines specific objectives and goals
and drives the future direction of the CCC while supporting its mission, vision and aspirations. Performance and
progress of the stated goals within the plan are tracked and catalogued on an ongoing basis.
Funding is requested for a small portion of the costs for our annual External Advisory Board meeting, Cancer
Center retreat and Program retreats.